Ultrasensitive Ion-Selective Optodes for Self-Testing of Blood Electrolytes

SUMMARY
Electrolyte imbalances are the cause or the consequence of a variety of endocrine, renal, cardiac, and hepatic
disorders. It has been envisioned that self-testing of electrolyte levels by patients will revolutionize the
management of chronic conditions such as hypoparathyroidism, arginine vasopressin deficiency, congestive
heart failure, and kidney failure, akin to the revolution witnessed in diabetes management through self-testing of
blood sugars. However, in contrast to the widespread success of minimally invasive self-monitoring devices for
glucose, there are currently no products designed for quantitative measurements of blood electrolytes by non-
healthcare professionals. Although blood gas/electrolyte analyzers have been prevalent in hospitals for decades,
the minimum required blood volume is hundreds of times greater than that of a typical glucose strip, and the
analyzer price is hundreds of times higher than that of a glucometer. These limitations prohibit their use in
decentralized settings such as patients’ homes for self-monitoring.
Using the calcium ion as an example analyte, we have recently developed a novel colorimetric ion sensor
(ultrasensitive ion-selective liquid optode) capable of detecting electrolytes in only a few microliters of whole
blood. The optode is a non-volatile and viscous oil that contains hydrophobic sensing chemicals including an
ionophore to recognize the analyte ion, a dye as the optical reporter, and an ion exchanger to maintain the charge
balance. The target electrolyte from blood is selectively extracted into the sensing oil to change the oil color. The
oil is uniquely formulated to yield an exceptionally large color response within the very narrow clinical range of
the electrolyte, ensuring high-precision and high-confidence measurements. In this project, we aim to 1) develop
ultrasensitive ion-selective optodes to measure blood electrolytes, including calcium, sodium, potassium,
magnesium, and chloride ions, for the management of corresponding diseases, 2) select the calcium sensor as
an example to conduct a clinical validation study using venous and fingerprick blood samples from patients with
thyroid and parathyroid disorders; 3) design a multiplexed sensing platform for simultaneous measurements of
multiple electrolytes in a drop of blood.
The handheld electrolyte monitor will consist of a stepper motor-based liquid control module, a mini camera
serving as the optical detector, and a single-use colorimetric sensor. The permanent component will cost a few
hundred dollars, while each disposable part will cost no more than a dollar. The required blood (1-3 microliters)
can be easily obtained through finger pricks using small-sized lancets without the finger squeezing that often
causes hemolysis. If successful, this home-use technology will empower patients to self-monitor their blood
electrolytes in a timely and frequent manner, minimizing complications and risks associated with their chronic
diseases.

Public health relevance
NARRATIVE Electrolyte disorders are linked to a variety of chronic conditions, including hypoparathyroidism, arginine vasopressin deficiency, congestive heart failure, and kidney failure. Frequent monitoring of blood electrolyte levels is crucial for the effective management of these disorders. This project aims to create an affordable and handheld monitor to enable self-testing of electrolytes at home using a small drop of blood collected from a fingerstick.